Multiplexed Assays for Improving Rheumatoid Arthritis Diagnostics

DESCRIPTION (provided by applicant): There is a need for multiplexed assay technologies that enable diagnostics and detailed characterization of rheumatoid arthritis. In this project we plan to discover new rheumatoid arthritis biomarkers and implement them in a panel of multiplexed assays. We propose a novel approach that offers significant advances over existing methods, including the ability to rapidly develop, validate, and implement highly multiplexed, high- performance assays. If successful, our long-term goal is to transfer these new assays to the clinic as valuable new tools for high sensitivity diagnostics and treatment decision- making.

Public health relevance
PUBLIC HEALTH RELEVANCE: We are developing multiplexed assays for rheumatoid arthritis. The assays will be useful for earlier disease detection, classification, and monitoring response to treatment. If successful, this project will improve rheumatoid arthritis diagnosis and aid therapeutic decision-making.